Bach1 as a molecular target in sepsis

ABSTRACT
In the US, 1.5 million people are affected by sepsis with a mortality of more than 250,000 annually.
Each year over 35,000 Veterans are hospitalized with sepsis, and high rates of post-sepsis
mortality and significant increases in healthcare facility use are reported among Veterans
surviving sepsis. We propose a bioenergetic approach to develop a novel treatment strategy for
sepsis. The transcription factor BTB and CNC homology 1 (BACH1) is a repressor of NRF2
function and has been shown to negatively regulate NRF2 binding to ARE sequences. Our recent
studies show that, Bach1 deletion improves organ function and survival following polymicrobial
sepsis induced by cecal ligation and puncture (CLP) with a concomitantly increased liver HO-1
expression. In this proposal, we will determine whether HO-1 is the mediator for the salutary effect
seen in Bach1-/- mice, whether there are other critical genes regulated by BACH1 independent of
NRF2, and whether transient modulation of BACH1 can improve organ function and survival in
sepsis. The proposed research is relevant to that part of VA’s mission that pertains to better
understand the causes of and develop or improve treatments for injuries and illnesses that afflict
Veterans. The outcome of this research will be significant because the fundamental knowledge
gained from this study is expected to advance methods to promote our Veteran’s healthy living.

Public health relevance
In the US, 1.5 million people are affected by sepsis, with a mortality of more than 250,000 annually. There is no effective treatment for sepsis, which is a major healthcare issue among the Veterans. Every year over 35,000 Veterans are hospitalized with sepsis. A high rate of post- sepsis readmission, post-sepsis mortality, and significant increases in healthcare facility use are reported among Veterans surviving sepsis. A number of immunomodulatory therapies that targeted sepsis were not successful in clinical trials. Our focus on bioenergetic modulation provides an alternative approach in sepsis treatmentOur studies, if successful, will result in the identification and preclinical confirmation of BACH1 as a molecular target in reducing or preventing mortality following sepsis, and identify possible mechanisms by which Bach1 deficiency is related to improved outcome.